IND-enabling development for IN-005, an inhaled muco-trapping mAb therapy against Influenza A

Project Summary
Seasonal influenza virus (INFV) infections represent a major public health burden. Although flu vaccines are
broadly available, they only offer modest effectiveness and have limited uptake. Current antivirals are only
modestly effective if given soon after symptoms emerge (~24-48hrs), which is achievable in less than half of
infected patients due to delays in seeking care and confirming diagnosis. Several neutralizing monoclonal
antibodies (mAb) against INFV have been advanced into Phase 2 studies over the past 2 decades. However,
they have all failed in clinical studies due to inability to consistently achieve therapeutic concentrations in the
respiratory tract (RT) following IV dosing. Indeed, in clinical studies, the subset of patients who experienced
the greatest clinical benefit were those with the highest levels of mAb in nasal swab samples. This suggests
that prior clinical failures were primarily due to insufficient distribution of mAb into respiratory fluids after IV
administration, not due to deficiencies of the mAbs themselves. Inhalon is advancing a pipeline of antiviral
mAbs to treat various acute respiratory infections, to be dosed directly into the RT via nebulization. Direct
inhaled delivery allows us to achieve far higher mAb concentrations in the RT than IV dosing. Inhalon also
incorporates into its mAb pipeline a largely underappreciated mAb effector function in mucus – trapping
individual viruses in mucus – which blocks the local spread of the infection and facilitates rapid elimination of
virions from the RT, removing a key source of antigens that can propagate infection-induced inflammation. We
believe Inhalon’s approach to combine localized delivery with optimized mucosal effector function is uniquely
well-suited to treat various acute respiratory infections, including INFV.
To quickly advance this concept into the clinic, we have in-licensed a broadly neutralizing mAb against
INFV-A from large pharma, with a well-established CMC package, existing GMP master cell bank, and
excellent safety profile across multiple clinical studies. We have termed this reformulated molecule IN-005, and
have developed formulations that support stable nebulization at high concentrations while maintaining physical
stability and functional binding. In Aim 1, we will verify whether inhaled dosing of IN-005 can improve survival
and reduce lung viral titers relative to oseltamivir standard of care, particularly when withheld until after
oseltamivir’s efficacious treatment window. We will, in parallel, submit a pre-IND to the FDA (Aim 2A) to
confirm the necessary preclinical and clinical pathway, and produce tox materials using an existing master cell
bank CHO cell line (Aim 2B). This will enable us to complete the key additional preclinical studies (inhalation
tox, nebulization characterization, Aim 3) that, in our experience with other mAbs in our pipeline, will support
advancing IN-005 into clinical studies. Successful completion of these studies will put IN-005 at the doorstep of
clinical studies as the first inhaled mAb therapy for INFV.

Public health relevance
Narrative Influenza virus (INFV), including avian influenza, continues to be a major public health burden despite the availability of flu vaccines and small molecule antivirals. Inhalon is developing IN-005 as an inhaled antibody therapy for INFV, which we expect to both provide immediate therapeutic benefit and also likely extend the duration before when the first dose must be given (beyond the first 48 hrs post-symptoms required by TamiFlu). This SBIR will verify the efficacy of IN-005 in a lethal challenge mouse model of INFV compared to current antiviral standard of care, conduct a pre-IND meeting with the FDA to confirm the preclinical and clinical pathway, produce a tox lot of IN-005, and conduct key IND-enabling studies to support advancing into the clinic.